POSTMENOPAUSAL ESTROGENS AND APOLIPOPROTEIN B METABOLISM

Women who take postmenopausal estrogens have lower LDL levels, which may explain in part their reduced incidence of cardiovascular disease. The mechanism of LDL reduction is unknown. We will use a nonradioactive tracer, trideuterated levine, to measure rates of LDL synthesis and catabolism during 1) estrogen treatment and 2)placebo.